Strategies for targeting astrocyte reactivity in Alzheimer's disease and related dementias

OVERALL – ABSTRACT SUMMARY
This P01— Strategies for Targeting Astrocyte Reactivity in AD and ADRD (STAR-ADRD) addresses the
(patho)physiologic roles of reactive astrocytes in Alzheimer’s disease (AD) and related dementias (ADRD).
Though highly significant to many disease phenotypes, astrocyte functions are under-investigated and have yet
to benefit from large-scale programmatic support from the NIH. To fill this void we have assembled a highly
accomplished and collaborative team from the University of Kentucky Sanders-Brown Center on Aging (UK-
SBCoA). The overarching goals of this project are to: (1) Use cell-specific targeting to modulate distinct aspects
of the reactive astrocyte phenotype. (2) Use cutting-edge technologies to assess the functional impact of reactive
astrocytes in intact preclinical mouse models of AD and ADRD pathologies. (3) Leverage UK-SBCoA and UK-
Alzheimer’s Disease Research Center (ADRC) resources to validate preclinical results in postmortem and living
human subjects. And (4) Use an integrated data pipeline approach to analyze and interpret data within and
across projects. Through these aims we will test the hypothesis that: interrelated reactive astrocyte
phenotypes drive major pathophysiologic features of dementia including cerebrovascular dysfunction,
hypometabolism, and impaired neuronal network function and fidelity. Projects are designed around a
clear understanding that dementia does not exist as a single pathological entity most of the time, but rather is
characterized by multiple brain pathologies. Project 1 (Astrocytic end-feet and VCID) will use MMP9
overexpression/knockdown in a model of cerebral small vessel disease to address astrocyte endfeet
degeneration. Project 2 (Astrocytic insulin signaling and AD) will overexpress/knockdown astrocytic insulin
receptors (IR) in an Aβ model to study the impact of impaired astrocytic IR signaling. Project 3 (Astrocytic
glutamate transport in AD and VCID) will overexpress/knockdown the astrocytic glutamate transporter SLC1A2
in a mixed Aβ-vascular model to assess the role of impaired glutamate transport in reactive astrocytes. Project
4 (Astrocytic KATP channels in LATE+HS) will overexpress/eliminate astrocytic ABCC9/SUR2 in a model of
LATE + hippocampal sclerosis to assess the role of KATP channels. Four Cores will support and further integrate
our Projects. Core B: Animal Vascular-Metabolic-Neural Network (VMN) will assess cerebrovascular, metabolic,
and neural network properties in mice using two-photon microscopy, MRI/MRS, microelectrode array neuro-
chemistry, and electrophysiology. Core C: Human Consultation-Biosamples-Biomarkers (CBB) will validate
results in mice using well characterized autopsy tissue, MRI, EEG, and fluid biomarker data from humans. And
Core D: Data Management and Biostatistics will establish a data pipeline for efficient categorization,
transformation, and statistical analysis of complex relationships between astrocyte interventions and endpoint
measures, within and between projects. Finally, an Administrative Core (Core A) will provide leadership,
coordination, integration, and administrative structure, so that the P01 goals are achieved.

Public health relevance
OVERALL - NARRATIVE This P01 will use cell specific targeting approaches and cutting edge in vivo assessment techniques in preclinical mouse models— validated by biomarker measures in human subjects— to unravel the role(s) of reactive astrocytes in the pathophysiology of Alzheimer’s disease and related dementias.